Single-cell dissection of chromatin architecture mechanisms connecting pathologic instability and transcriptional silencing

Short tandem repeat regions (STR) are distributed evenly across the human genome, and recent genome-wide
studies have demonstrated that STRs are polymorphic across individuals and linked to gene expression levels.
STR instability at key genomic loci has been causally linked to disease pathophysiology in a range of expansion
disorders. We recently demonstrated that nearly all disease-associated STRs co-localize with boundaries
demarcating topologically associated domains (TADs). Moreover, we have observed that pathologic STR
instability and transcriptional silencing can destroy the associated boundary and shift genomic loci to the nuclear
periphery. These results now open critical unanswered questions regarding whether and how STR expansion
and pathologic alterations in gene expression are functionally linked to boundary integrity and radial positioning.
Here, we focus on the prototypic repeat expansion disorder Friedreich’s ataxia (FRDA) in which expansion of a
GAA STR in the first intron of the FRATAXIN (FXN) gene results in cardiac and neuronal pathology. The cardiac
pathology, specifically hypertrophy, fibrosis, and occasional dilation of the ventricle, is the etiology of significant
FRDA mortality. GAA expansion is associated with the silencing of FXN transcription and a repositioning of the
locus to the nuclear periphery. However, it remains unclear if the change in genome folding, radial positioning,
or reduced expression drives STR expansion or vice versa. A major technical barrier contributing to this
knowledge gap is that STR instability and genome folding are classically evaluated in bulk populations, however
they exhibit tremendous variation across individual somatic cells of the same subtype and among cell types
within a pathologically affected tissue. Here, we seek to decipher the causal link among STR instability,
transcription, radial positioning, and genome folding. Our central hypothesis is that disruption of long-range loops
is the initial event triggered by STR expansion leading to a cascade of heterochromatin spreading, silencing, and
loss of radial positioning. We will test our hypothesis by generating genome-wide, single-cell maps of chromatin
accessibility, expression, and the repressive H3K9me3 heterochromatin mark in GAA-expanded and control iPS
cells and iPS-derived cardiomyocytes. We will integrate genomics data with single-cell sequential
Oligopaints/OligoSTORM imaging of TADs and local chromatin structure, as well as single molecule RNA FISH
for FXN expression. We will implement multiple genome engineering strategies, including dCas9-VP64 FXN
activation and dCas9-CTCF loop re-engineering in FRDA GAA-iPS cells, and dCas9-Krab-Dnmt3a FXN
silencing and dCas9-Krab CTCF-mediated loop disruption in healthy iPS cells. We will assay the effect of
genome engineering approaches on TADs, radial positioning, STR length, and FXN expression in single cells.
Successful completion of the proposed work will shed light on the pathophysiological mechanisms underlying
repeat expansion disorders by deciphering the cause-and-effect relationships among genome folding, radial
positioning, transcription, and STR expansion.

Public health relevance
Local instability of short tandem repeat tracts causes severe pathologic disruption of multiple cell types and organ systems in a cohort of trinucleotide repeat expansion disorders. To inform new therapies, we seek to understand the functional link between repeat expansion and higher-order chromatin folding patterns in the nucleus of pathologically affected cell types at a single-cell resolution.